BIOCHEMISTRY: MECHANISM OF ACTION OF PENICILLIN

The general objective of the present work is to study in as much detail as possible the mechanism of inhibition of bacterial growth by penicillins, cephalosporins and other Beta-lactam antibodies. During the present phase the main effort will be: 1) to elucidate the sequences of the active site peptides of the high molecular weight penicillin binding proteins of Escherichia coli (PBPs 1a, 1b, 2 and 3) in order to localize the active site peptides within the primary amino acid sequences derived from DNA clones, 2) similarly, to identify and localize the hydrophobic membrane-spanning peptide(s) of these penicillin-binding proteins as well as that of PBP 5 and 3) to crystallize one or more of these penicillin-binding proteins, either in the presence of the detergent or as a catalytically active water soluble proteolytic degradation product, in order to determine the x-ray crystallographic structure. These data should provide much useful information for the improved rational design of penicillins, cephalosporins and related Beta-lactam antibiotics.